An Automated Compound Management System for Small Molecule Drug Discovery

ABSTRACT
Southern Research (SR) is requesting funds for the purchase of a Hamilton Verso M3 (“Verso”) to assist in the
execution of drug discovery and chemical biology projects. The Verso will serve as the small molecule
repository for SR, UAB, and several institutions in the region, replacing the current de-centralized model. This
will complement the role of SR as the provider of high-throughput screening, chemistry, and other downstream
drug discovery activities to the participating institutions. The Verso will store samples in a -20 ºC dry
environment, enable single container retrieval (“cherry-picking”), allow active thawing within the system,
provide an up-to-date inventory of the contents, and provide real-time monitoring of the system status. These
primary features of the system will serve to protect the samples’ integrity, replace the current manual steps of
retrieval and storage, and improve the processes that track samples from source container to experimental
results. Activities that the Verso service will support include primary screening to identify active compounds,
confirmation and counter-screening of primary and virtual screening hits, in vitro potency determinations during
hit-to-lead and lead optimization stages, drug repurposing screening, and fundamental chemical biology
studies. The projects that will benefit from the Verso represent multiple stages along the discovery pipeline
ranging from early target identification and validation studies to those at the threshold of clinical trials. As
Southern Research charts a path of growth, the need for small molecule drug discovery will grow as well.
Currently, SR’s collection is comprised of over 4000 plates (containing 320 compounds each) and over 66,000
single containers (tubes and vials) managed across groups with suboptimal manual processes. Estimated
growth is expected to consist of approximately 1600 individual samples per year and the acquisition of a new
100,000 compound library in multiple formats to serve the needs of the users. The user base will grow by
progressing early-stage projects from pilot screen to a full screening campaign and by identifying promising
new targets and approaches to fund through the Alabama Drug Discovery Alliance (ADDA). The
implementation of an automated compound management system will be critical for supporting this growth and
contributing to ongoing NIH-funded projects and newly emerging drug discovery programs.

Public health relevance
PROJECT NARRATIVE Small molecule collections are the starting points for many pursuits to discover therapeutic treatments for unmet medical needs. Identifying the small molecules that possess the desired activity in the tests that are run requires that the samples have maintained their integrity during storage and that processes are in place to accurately track sample movement. Scaling this process to address the needs of multiple projects with hundreds of thousands of small molecule samples greatly benefits from an automated, environmentally- controlled system to store, retrieve, and track the tested samples.